Leveraging Large Linked Datasets and Novel Analytic Methods to Understand the Long-term Effectiveness and Value of Cardiac Rehabilitation in Understudied Populations

PROJECT SUMMARY
Cardiac rehabilitation (CR) combines supervised exercise, risk factor modification, and psychosocial support in
a structured program that may lower cardiovascular morbidity, mortality, and healthcare spending in selected
patients with cardiovascular disease. Yet only 1 in 4 eligible patients in the U.S. receives CR, with marked
disparities by sex, race/ethnicity, socioeconomic level, and rurality. Barriers to uptake include uncertainty of
long-term benefit among clinicians and patients, limited availability of local CR facilities, and high out-of-pocket
costs. Most randomized clinical trials of CR in the U.S. did not enroll diverse populations, were too small to
evaluate heterogeneity, and could not examine long-term outcomes. Moreover, major advances in
cardiovascular therapies – such as transcatheter valve replacement or new treatments for heart failure – may
have altered the effectiveness of CR, limiting the generalizability of past trial data. Observational analyses of
real-world data may provide contemporary insights, but commonly used statistical methods are challenged by
immortal time bias and confounding, particularly when treatments, like CR, need to be sustained over time.
This project applies novel causal inference methods that have been specifically developed to address these
limitations to large, diverse datasets incorporating administrative claims, electronic health records, and a
cardiovascular registry, all linked with national health system and community-level socioeconomic data. Aim 1
will evaluate the effectiveness of CR in diverse populations of Medicare, Veterans Health Affairs, and
commercial insurance beneficiaries. It will use the target trial framework (which uses observational data to
emulate the hypothetical trial that would definitively answer the research question of interest) and quasi-
experimental designs (which exploit random variation in CR use). It will examine both in-person and virtual CR,
the uptake of which has increased since the COVID-19 pandemic. Aim 2 will examine individual-level
variability in response to CR using novel risk score- and effect score-based analyses to derive personalized
estimates of treatment benefit. The final validated score-based model will be used to develop an online tool so
that clinicians can incorporate this information into shared decision-making regarding CR use. Aim 3 will use
time-driven activity-based costing to estimate the cost of delivering in-person or virtual CR, and use nationally
representative simulation models to evaluate the population health benefit and cost-effectiveness of CR.
IMPACT: This research, which will be the largest and most comprehensive contemporary evaluation of CR in
the U.S., will directly address key knowledge gaps identified by the Centers for Disease Control's Million
Hearts Initiative. Our multidisciplinary team will evaluate the long-term effectiveness of CR in diverse
populations to increase evidence-based CR uptake, produce personalized estimates of treatment benefit to
facilitate shared decision-making, and project long-term cost-effectiveness to stimulate strategic investments
needed to enhance equitable access to this underutilized guideline-directed therapy.

Public health relevance
PROJECT NARRATIVE Cardiac rehabilitation, a structured program combining exercise training and risk factor management, may improve the health of patients with heart disease, but few eligible patients in the US receive the therapy. The proposed research will use novel statistical methods to examine the effectiveness of in-person and virtual cardiac rehabilitation in diverse populations, produce personalized estimates of benefit, and project the long- term effect of cardiac rehabilitation on population health and healthcare costs. The results of this study will help patients, clinicians, and policymakers make informed decisions about cardiac rehabilitation, and equitably advance the health of millions of US adults living with heart disease.